Great Plains Center for Agricultural Health

PROJECT SUMMARY/ABSTRACT – GREAT PLAINS CENTER FOR AGRICULTURAL HEALTH (OVERALL)
The Great Plains Center for Agricultural Health conducts research and provides outreach to reduce the
burden of injury and illness facing Midwest agricultural producers, particularly those hazards associated with
both large and small row crop and livestock/animal production. This Center will serve a nine-state region: who
share these production similarities: Illinois, Indiana, Iowa, Kansas, Minnesota, Missouri, Nebraska, Ohio,
and Wisconsin. Our vision of safe and healthy agricultural communities is accomplished through basic
and applied research, use of participatory approaches, and theory-driven education and translation activities.
Our research projects are designed to address multiple hazards important to both the NIOSH national strategic
priorities and priorities for our region’s farming workforce. The research questions being proposed will: reduce
the burden of back pain from a lifetime of tractor use, provide resources to help families of aging farmers
transition to safer work at multiple stages of dementia, provide tools to help farmers identify and reduce high-
risk hazards in their physical environment, reduce injuries from farm vehicles on roadways, and improve the
respiratory health of livestock producers and the animals they raise. Research proposes to develop innovative
technologies needed to close gaps in knowledge (whole-body vibration), awareness of hazards (safety
checklist app), and equipment (air quality systems), and innovative partnerships (e.g., Alzheimer’s Association,
state extension health educators) bring new collaborators with unique skills to contribute to agricultural injury
reduction. Partnerships throughout the Center projects and cores, including advisory boards and focus group
participants, will provide essential information to enhance the adoption of tools being developed and/or tested
across the Center portfolio. The lessons learned from our research initiatives will be translated into outreach
materials by being incorporated into national educational curricula, disseminated through partners, and
incorporated into multimedia discussions (social media, print media-Safety Watch, and FarmSafe podcasts) to
aid in the dissemination and uptake of these best practices. The Center will establish and support systems to
foster communication, identify and build strategic partnerships, and assess the needs of the agricultural
community. Our evaluators will work within all projects and Cores to maximize our ability assess the Center’s
contributions to improved health and safety outcomes for our region’s farmers. The Great Plains Center for
Agricultural Health has demonstrated its contributions to improving knowledge and practices to protect the
health and safety of agricultural workers throughout the Midwest, and we are ideally positioned, with strong
regional collaborators, to generate and disseminate evidence-based practices, guidelines, and controls to
protect this essential workforce.

Public health relevance
PROJECT NARRATIVE – GREAT PLAINS CENTER FOR AGRICULTURAL HEALTH (OVERALL) The Great Plains Center for Agricultural Health is a regional center dedicated to conducting research and providing outreach to protect the health and safety of agricultural workers across our nine-state upper Midwest region. Our research will identify risk factors, develop technology, and evaluate interventions to reduce the burden of injury and disease associated with risk factors relevant to our region’s intensive row crop and livestock production activities -- vehicle vibration, roadway hazards, indoor air quality, and cognitive declines in older workers as well as persistent safety hazards. We will share lessons learned by building expertise throughout the region by developing evidence-based curricula targeting multiple audiences (e.g., youth, college, and healthcare), communicating through storytelling using traditional and innovative multi-media platforms, and building new partner networks to collaboratively influence safety and health perceptions and behaviors of farm workers.